TRD2: Circular Ranging OCT

Project Summary
TRD-2
TRD project 2 will develop imaging platforms based on novel circular ranging (CR) architectures of optical
coherence tomography. Specific Aim #1 addresses long-standing challenges to using OCT in open surgery.
Conventional approaches burdened the surgeon with cumbersome equipment and required disruptions in
workflow. We will leverage the depth-independence of CR to enable a head-mounted OCT microscope that
can continuously survey the surgical field. This OCT loupe platform will be specifically developed to provide
improved visualization of nerves to prevent accidental injury to these delicate and critical tissues, and thereby
avoiding some of the most feared surgical morbidities. Specific Aim #2 integrates recent advancements in
quantitative flow imaging with extremely rapid retinal CR-OCT technology to enable a platform for wide-field
angiography and quantitative flow mapping in the human retina. Quantitative flow imaging will enable
comprehensive, pulse resolved maps of the non-capillary retinal vascular networks, positioning investigators to
decipher the interaction of retinal perfusion and disease. Wide-field angiography will reduce barriers that have
limited clinicians and scientists from reliably and routinely imaging the peripheral retina Through these aims,
TRD-2 will develop, validate, and deliver innovative technologies to our collaborating investigators and to the
broader biomedical community.